Optimizing Treatment for Human Papillomavirus-Associated Oropharyngeal Cancer in Older Adults

SUMMARY
Human papillomavirus-associated oropharyngeal cancer (OPC) is one of the fastest rising causes of cancer
incidence (3%/year) in the US, with a pronounced increase (≥4%/year) among older adults (≥65 years). The
OPC burden is projected to double (>30,000 new cases annually) over the next few decades, with >60% of new
cases occurring in patients aged ≥65 years. Although standard of care treatment for OPC results in excellent
survival, it can cause devastating chronic toxicity and impaired long-term quality of life (QOL). As a result, a
number of clinical trials and real-world studies have evaluated protocols to de-intensify treatment for patients
with OPC. However, none of the studies considered the evolving OPC epidemiology and assessed the effect of
aging and multimorbidity on treatment toxicity, oncologic outcomes, and QOL. Due to their comorbidity burden
and narrow therapeutic index, older adults with OPC are more susceptible to treatment-related adverse events
(AEs), suffer from worse QOL, and have an increased mortality risk from competing events. In addition, patient
preferences regarding the tradeoff between survival and treatment toxicity, data that are critical to guide
preference-concordant shared decision-making, have not been fully characterized in this population. As a result,
treatment of OPC among older adults is guided by inappropriate extrapolation of data from studies in younger
patients. To address this critical gap, disease simulation modeling can be used to generate in-silico trials to
compare harms vs benefits of different treatment paradigms over the patient’s lifetime in the context of aging
and multimorbidity. This project will leverage several large representative data sources with over 200,000 OPC
(>122,000 older adult) cases to characterize treatment outcomes among patients with OPC as a function of age
and multimorbidity and evaluate preferences for the tradeoff between survival and treatment toxicity among 150
OPC survivors. We will use these collective inputs to synthesize a novel micro-simulation model
(Simulation model of OropharyngeaL cAnCEr treatment among older adults [SOLACE]), and then perform in-
silico trials using SOLACE to compare harms and benefits of OPC treatment, particularly among older adults
and those with multimorbidity. Our Aims are: (1) To characterize the impact of aging and multimorbidity on (a)
treatment outcomes (AEs, oncologic outcomes, QOL) and (b) treatment priorities and preferences among
patients with OPC; (2) To synthesize, calibrate, and validate a micro-simulation model (SOLACE) of OPC
treatment outcomes over the survivorship duration in association with age and multimorbidity; and (3) To
compare the harms vs benefits of common treatment paradigms (including de-intensification) over the lifetime of
patients with OPC in the context of aging and multimorbidity using SOLACE. Study findings could transform
clinical decision-making for OPC, maximize benefits and reduce harms, and inform evidence-based, patient-
centered, and preference-concordant decision-making for this rapidly growing patient population.

Public health relevance
NARRATIVE The objective of this study is to advance oropharyngeal cancer treatment among older adults. Towards this objective, we will evaluate treatment-related adverse events and quality of life in association with age and multimorbidity among patients with oropharyngeal cancer and integrate these inputs into a novel microsimulation model of oropharyngeal cancer prognosis and survivorship to perform comparative effectiveness analyses. Our results will optimize oropharyngeal cancer treatment among older adults by reducing treatment toxicities and maximizing survival and quality of life.